Penn Postdoctoral Training Program in the Ethical, Legal and Social Implications of Genetics and Genomics

Enter the text here that is the new abstract information for your application.
Rapid advances in genomic technologies are transforming our understandings of both human health and human history. These technologies also promise unprecedented power to intervene on the bodies of individuals with or at risk of disease and even to alter the identities or futures of individuals not yet born. Such knowledge and power imply immense responsibility to use them in ways that promote core ethical values, including individual and collective welfare, social justice, protection of the vulnerable, and respect for both the autonomy of persons and the interests of communities. Fulfilling these responsibilities requires a highly trained cadre of interdisciplinary scholars prepared to engage critically and respectfully with the profound ethical, legal and social challenges raised by genomic technologies. Responding to this need, the fundamental goal of the Penn Postdoctoral Training Program in the Ethical, Legal and Social Implications (ELSI) of Genetics and Genomics is to prepare trainees for success as creative, independent investigators in the field of ELSI research. The program, housed within the Department of Medical Ethics and Health Policy at the Perelman School of Medicine, will achieve this goal through three core components: 1) mentored original research leading to high-impact empirical and conceptual scholarly publications; 2) individualized didactic training including and, when appropriate, a Master of Science in Medical Ethics degree; and 3) intensive career development preparation. Trainees will participate as fellows for three years. An outstanding program faculty, consisting of 13 experienced ELSI scholars and mentors with appointments in departments at the Perelman School of Medicine, the School of Arts and Sciences, and the Penn Carey Law School, will serve as preceptors to program trainees. Trainees will present at and participate in the Department of Medical Ethics and Health Policy’s monthly works-in-progress and seminar series, attend a wide range of seminars and conferences across the University focused on genetic medicine and science as well as on ethics, law, economics and health policy, and present at national meetings. Trainees will also gain exposure to genetic medicine through shadowing expert geneticists and counselors drawn from the full spectrum of adult, pediatric and reproductive genetics practice. Finally, trainees will serve as members of one of the UPenn institutional review boards (IRBs) that review ELSI-related research. The program will ensure the fullest possible range of disciplines among enrolled trainees by extensive targeted outreach.

Public health relevance
Genomic technologies promise to transform our understandings of human biology and history and offer unprecedented power to influence the health of individuals and generations. Such knowledge and power imply immense responsibility to use them in ways that promote social and ethical values in the service of the public’s health. This research training program aims to nurture a cadre of interdisciplinary scholars prepared to engage critically and respectfully with, and advance our knowledge and understanding of, the profound ethical, legal and social (ELSI) challenges that genomic technologies raise.